Induce and Image extrachromosomal DNA in human glioblastoma avatar

SUMMARY/ ABSTRACT
Glioblastoma (GBM) is an isocitrate dehydrogenase wildtype cancer that accounts for 80% of all primary
malignant brain tumors in adults with no effective treatment. One major factor contributing to therapeutic
resistance is cell state heterogeneity. However, the molecular mechanisms behind this phenomenon are not well
understood, posing a significant challenge to addressing therapeutic failure. One of the most common genetic
lesions in GBM patients is the epidermal growth factor receptor (EGFR) gene amplification, typically in the form
of extrachromosomal DNA (ecDNA). The circular, megabase-sized ecDNA contains oncogenes like EGFR and
regulatory elements such as enhancers, leading to significant oncogene amplification and expression. ecDNA
does not have centromeres and is believed to randomly segregate into daughter cells thereby conferring cancer
cell heterogeneity, promoting cancer genome evolution, and mediating therapy resistance. Moreover, ecDNA
can also facilitate genetic recombination, generating new regulatory circuitry and expressing variants, including
clinically common variant EGFRvIII. For these reasons, ecDNA has been found inversely correlated with poor
survival of GBM patients. Despite the exciting yet presumptive connection of ecDNA to GBM, fundamental
questions of ecDNA in GBM pathobiology remain surprisingly unanswered. First, does EGFR ecDNA causally
fuel GBM tumorigenesis? Second, how does centromereless ecDNA propagate to daughter cells during mitotic
inheritance? Third, what are the molecular mechanisms by which ecDNA promotes GBM heterogeneity? These
knowledge gaps are due to i) lack of a clinically relevant, genetically modifiable model system to recapitulate
GBM pathobiology, ii) shortage of effective methods to de novo engineer ecDNA synthesis in non-transformed
cells, and iii) paucity of unbiased ecDNA labeling and optimized imaging modality to longitudinally trace the
dynamics of ecDNA during mitosis in living cells. This R21 exploratory application utilizes the principal
investigator’s considerable expertise in CRISPR engineering, ecDNA imaging, stem cell biology, and single-cell
genomics. We propose to ab initio engineer the induction of ecDNA from genetically normal human induced
pluripotent stem cells (hiPSCs) and to orthotopically engraft hiPSC-derived neural progenitor cells to directly
assess the role of ecDNA in GBM tumorigenesis. We will combine live-cell super-resolution imaging and single-
cell sequencing to evaluate the role of EGFR ecDNA to GBM heterogeneity. Unlike cell lines or common mouse
models that typically lack of tumor heterogeneity, our engineered hiPSC system provides a novel platform to
examine the causality and mechanism of EGFR ecDNA in GBM transformation and heterogeneity. The live-cell
super-resolution imaging and quantitative analysis framework will provide comprehensive tracing of ecDNA
dynamics during mitotic inheritance and extraction of potentially new regulatory principles for genetic propagation.
This genetically defined 'avatar' system offers a new way to model GBM etiology in the lab and is set to find new
therapeutic targets to tackle GBM's heterogeneity for better treatments.

Public health relevance
PROJECT NARRATIVE Glioblastoma is an incurable brain tumor characterized by the amplification and mutation of the driver oncogene EGFR on extrachromosomal DNA (ecDNA), which contributes to genetic heterogeneity and therapeutic resistance. This project aims to synthetically induce EGFR ecDNA formation and monitor its live-cell mitotic inheritance dynamics in a human glioblastoma model using engineered human induced pluripotent stem cells. The objective is to elucidate the functional role and molecular mechanisms of EGFR ecDNA in glioblastoma pathobiology, thereby laying the groundwork for new therapeutic strategies targeting this heterogeneous and lethal brain tumor.